A novel targeted antibody therapeutic to treat ovarian cancer

PROJECT SUMMARY
Ovarian Cancer (OvCa) is the fifth leading cause of cancer deaths for women and is associated with very low
survivability. Current treatment strategies for OvCa largely include surgery and chemotherapy. Chemotherapy,
which often involves platinum-containing drugs and taxanes, can be effective; however, many patients
experience complications due to side effects and/or resistance to the chemotherapy. Alternative options are
needed to provide effective treatment strategies for OvCa patients. Immuno-oncology (IO) drugs have shown to
improve treatment outcomes for some cancers by enabling a patient’s immune system to launch an immune
attack against the tumor. However, the efficacy of current IO drugs (e.g., immune checkpoint inhibitors (ICIs)) is
low due to their inability to generate immunogenic tumors. Current IO drugs stop immunosuppression only from
cancer cells; immunosuppression from immunosuppressor cells such as the Myeloid Derived Suppressor Cells
(MDSCs) remains intact thereby sustaining an immunosuppressive tumor microenvironment. While eliminating
MDSCs is perceived as a strategy for overcoming immunosuppression, clinical trials have shown that eliminating
MDSCs alone is insufficient to reduce tumor burden. Current drugs that can eliminate MDSCs are unsuitable as
they lack selectivity to target MDSCs and non-specifically deplete other immune cells. Hence, tumor specific
elimination of only MDSCs whilst eliminating cancer cells is a major unmet clinical need.
TRIO Pharmaceuticals (TRIO) is fulfilling the need by developing a new class of cancer drugs, referred to as
TRAILBody™, which are designed to eliminate both cancer cells and MDSCs by selective activation of
TRAIL-R2 mediated apoptosis without engaging immune effector cells and conjugated toxins. TRAILBodies
target cancer cells by binding a tumor specific antigen and target MDSCs by binding FcγRII. TRAILBodies
eliminate both cancer cells and MDSCs by TRAIL-R2 mediated apoptosis upon engaging the tumor specific
antigen and FcγRII, respectively. In this SBIR proposal, TRIO is developing a TRAILBody™ for OvCa: αFOLR1
× TRAIL-R2, referred to as TRIO-628. TRIO-628 is designed to improve OvCa treatment efficacy by generating
immunogenic tumors via eliminating cancer cells by targeting FOLR1 (overexpressed in OvCa) and eliminating
MDSCs by targeting FcγRII. Preliminary studies have shown a high degree of selectivity of αFOLR1 × TRAIL-
R2 for its targets and enhanced anti-tumor activity in comparison to lexatumumab. The goal of the Phase I
program is to establish TRIO-628 as an OvCa drug. This goal will be met through the execution of two Specific
Aims, which will involve in vitro assessments of the selectivity of TRIO-628 in depleting MDSCs and enhancing
tumor immunity and an in vivo efficacy study of TRIO-228 using a platinum resistant patient-derived xenograft
model. Successful completion of Phase I will provide critical in vivo proof-of-concept data for using TRIO-628 to
treat OVCA and support a Phase II proposal focused on safety and tolerability studies and translation studies to
advance the IND efforts.

Public health relevance
PROJECT NARRATIVE Ovarian cancer is the fifth leading cause of cancer deaths for women with a 5-year survival rate of 50%. Current treatment strategies are largely ineffective as there is a high rate of recurrence, thus alternate treatments that are safe and effective are direly needed. Trio Pharmaceuticals (TRIO) is developing a novel antibody drug (TRIO- 628) designed to specifically eliminate cancer cells and myeloid derived suppressor cells, while leaving normal cells unharmed.